Impact of Amyloid and Tau on the Aging Brain: The Harvard Aging Brain Study

SUMMARY—OVERALL. The Harvard Aging Brain Study (HABS) was established nine years ago to elucidate
the impact of the hallmark proteinopathies of Alzheimer’s disease (AD), i.e., amyloid-beta (aβ) and tau, as
assessed by PET imaging, in clinically normal older individuals. This is a competing renewal application for a
third cycle of the HABS Program Project Grant (PPG) to continue our longitudinal cognitive and multi-modality
imaging assessments of an extremely dedicated and richly phenotyped cohort of participants (currently age 51-
94, with diversity in ethnicity and socioeconomic status), and to leverage innovative technology to advance our
quest to better understand cognitive aging and preclinical AD. We have made excellent progress in achieving
the scientific goals of our second grant cycle, with over 100 research publications during the past four years
that have informed ongoing prevention trial designs and international initiatives on the study of AD and other
age-related pathologies. Our overall goals in this renewal are to: 1) Go earlier: investigate the earliest stages
of aβ and tau accumulation, evaluating specific anatomic patterns of progression, and the interactions of these
pathologies in the “pre-preclinical” phase of AD. 2) Go broader: investigate potential modulating factors, such
as vascular risk, physical activity, and systemic inflammation that may independently contribute to cognitive
decline, and interact with aβ and tau to accelerate cognitive decline. 3) Go deeper: explore novel measures of
synaptic integrity and utilize multifaceted digital technology to capture specific alterations in cognitive
processes. 4) Go faster: enable more rapid and efficient assessment of change in imaging and cognitive
measures over shorter time intervals, and ultimately predict progression on clinically meaningful outcomes. We
propose five Cores, including a new Biomarker Core, that will support four Projects: Project 1: Investigate
longitudinal aβ and tau PET relationships and identify in vivo pathoanatomic stages detectable over the course
of preclinical AD. Project 2: Investigate the contribution of other factors that modulate clinical decline, including
vascular disease, physical activity, and exploratory blood biomarkers of neural injury and inflammation. Project
3: Evaluate longitudinal multi-modality imaging measures of synaptic function and explore a novel PET tracer
of synaptic integrity. Project 4: Investigate the determinants of cognitive decline, optimize rapid detection with
novel digital measures, and establish the clinical meaningfulness of early cognitive changes. This HABS PPG
renewal will leverage an outstanding group of multidisciplinary investigators, access to cutting-edge imaging
and cognitive assessment technology, and an extremely well-characterized cohort with some of the longest tau
PET follow up in existence. The additional longitudinal assessments will allow us to determine the factors that
promote healthy brain aging vs. those that confer susceptibility to accumulating aβ and tau, and vulnerability
vs. resilience to cognitive decline in the setting of early AD pathology, with the ultimate goal of accelerating
progress towards the effective prevention of cognitive decline along the trajectory of preclinical AD.

Public health relevance
NARRATIVE. The Harvard Aging Brain Study is a longitudinal study aimed at improving our understanding of brain aging and the earliest (preclinical) stages of Alzheimer’s disease. This study acquires imaging data to detect early brain changes related to Alzheimer’s disease, including amyloid plaques and tau tangles, as well as functional and structural imaging data, and detailed assessments of memory and other cognitive processes. Our ultimate goal is to provide knowledge that will accelerate progress towards the successful prevention of cognitive decline due to Alzheimer’s disease.